Career Enhancement Program

PROJECT SUMMARY/ABSTRACT – CEP
The goal of the Career Enhancement Program (CEP) of the MSK Pancreas SPORE is to support and mentor
the most promising and motivated early-career investigators to prepare them for independent careers in
translational research focused on malignancies arising in the pancreas. The CEP leadership team has a strong
publication record, a history of successful mentorship, and a sustained commitment to education/training. The
CEP will: 1) recruit early-career investigators to the field of translational research in pancreatic cancer to enhance
the overall translational research capability of the SPORE and bring fresh ideas and new talent to our program,
and 2) provide these individuals the scholarly basis and mentorship needed for effective translational research
in pancreatic cancer. CEP funds, supplemented by institutional funds, will allow us to support up to two
exceptional candidates each year. Early-career investigators (applied and basic scientists, clinicians, and
physician-scientists within 2 years of their faculty appointment) with a demonstrated interest in pancreatic cancer
research from MSK, from institutions within the Tri-Institutional Program (Weill Cornell Medical College or
Rockefeller University), or institutions within and outside of New York City will be eligible to apply.
Applications will be peer-reviewed by the CEP/DRP Selection Committee, which is composed of the SPORE
PIs, DRP and CEP Leaders, select MSK Departmental and Divisional Chairs, and representatives from the
MSK Equality, Diversity & Inclusion Council. The most promising candidates, with the most meritorious
mentored research projects based on defined review criteria, will be selected. Special emphasis will be placed
on recruiting qualified women and members of underrepresented populations, and on projects focused on
issues pertaining to health care disparities in pancreatic cancer. CEP awardees will prepare an individualized
development plan with their clinical and/or laboratory mentor(s), and take part in various educational
programs, conferences, and curricula at MSK that support their career development. CEP awardees will have
full access to all SPORE Core facilities and expertise, and will be an integral part of monthly SPORE
meetings, where they will present their research. CEP recipients will be formally evaluated annually, and
training will be modified when appropriate. Metrics of success for CEP awardees include presentation/
publication of original research, successful competition for independent research support, establishment of
new collaborations, and institutional recognition by academic promotion.

Public health relevance
NARRATIVE Not applicable.